Gene Editing vs Neutrophil Elastase Inhibitors for Treatment of ELANE Associated Neutropenia

PROJECT SUMMARY
Mutations in ELANE, the gene for neutrophil elastase (NE), are the most frequent cause of both cyclic
neutropenia (CyN) and severe congenital neutropenia (SCN). The product of mutant ELANE, mutant
neutrophil elastase, acts in a dominant, cell-intrinsic fashion to disrupt neutrophil formation. The mutant
enzyme initiates apoptosis via the unfolded protein response (UPR). Transfection of mutant ELANE into a
myeloid cell line, HL60 cells, leads to a failure of maturation of myeloid progenitor cells and cell death by
apoptosis. Bone marrow primary myeloid cells or iPSCs from patients with SCN and CyN have the same defect
in neutrophil formation, maturation and survival.
Granulocyte colony-stimulating factor is a very effective subcutaneous treatment for most patients, but there
are lingering concerns about its contribution to the patients' risk of developing MDS/AML. A cell permeable,
orally active inhibitor of neutrophil elastase and knocking down expression of the mutant gene can correct
ELANE associated neutropenia in laboratory models of this disorder. However, these exciting findings are
based on testing only a few of more than 130 known mutations in ELANE found in patients with SCN and CyN.
It is very important to show that pharmacological or genetic silencing is effective across the spectrum of
mutants, because genotype-phenotype studies and clinical observations indicate that some mutations are far
more serious than other mutations. The proposed studies will utilize two cellular models, iPSCs and HL60
cells, to show potential advantages and disadvantage of each strategy focusing on the severity of disease
associated with the mutations.
Goal: To hasten development of novel therapies for SCN and CyN.
Specific Aims:
Aim 1. Generate CRISPR/Cas9 mediated mutant ELANE knock-ins (KI) in HL60 cell lines expressing a wider
diversity of mutant ELANEs. Perform CRISPR/Cas9 knock-out (KO) in these lines. Compare the effectiveness
of MK-0339 versus KO to promote cell proliferation, survival and differentiation across the spectrum of these
mutations, e.g., selected by type of mutation, frequency in populations and associated clinical severity.
Aim 2. Create additional iPSC lines from SCN/CyN patients with diverse ELANE mutations and generate
CRISPR/Cas9 mediated ELANE KO in these lines. Compare effectiveness of KO versus MK-0339 to correct
defects in cell proliferation, maturation and survival in these cell lines.
Aim 3. Compare the functional properties of neutrophils produced by ELANE KO versus MK-0339.

Public health relevance
PROJECT NARRATIVE Patients with severe congenital neutropenia and cyclic neutropenia have a hereditary blood disorder usually caused by mutations in the gene for neutrophil elastase, the gene ELANE. Neutropenia predisposes these patients to recurrent and life threatening infections. We propose further studies of an orally active drug that we have found to correct ELANE associated neutropenia in laboratory models and compare its effectiveness to CRISPR/Cas9 genetic knocking out of expression of mutant ELANE, a strategy that also can correct neutropenia.